Technologies for Directed Evolution of Glycoaptamers

Project Summary/Abstract
The goal of this Focused Technology R01 project is to develop technologies for rapid discovery
of inhibitors of carbohydrate-binding proteins (CBPs). Carbohydrate-protein interactions are
critical in numerous processes including host-pathogen recognition, cell adhesion and cell
signaling, cancer angiogenesis, immune suppression, heart/liver/lung/eye fibrosis,
atherosclerosis, diabetes, and rheumatoid arthritis, to name a few examples. However, selective
disruption of specific CBP interactions is challenging in vivo. CBPs generally bind weakly to
individual glycans, with higher affinity (avidity) or specificity coming from multivalent interactions
to clustered glycans or interactions with nearby non-carbohydrate elements. A given CBP also
usually binds to various glycans. To untangle the complex web of CBP functions, it is important
to have a way to rapidly develop a specific and potent inhibitor of a CBP that can be used in the
relevant in vivo context. To this end, we propose two Aims: 1) to develop multivalent glyco-F-RNA
aptamers, in which a nuclease-resistant, F-RNA backbone is evolved to present simple glycans
in a manner that is selectively recognized by a CBP of interest; 2) to develop monovalent glyco-
F-RNA aptamers, in which a simple glycan provides a binding “foothold” for the CBP of interest,
which the evolved F-RNA component confers additional binding affinity and specificity through
interactions auxiliary to the glycan-binding pocket.

Public health relevance
Project Narrative Carbohydrate binding proteins (CBPs) are a broad category of proteins involved diverse biological processes that either guard against disease or that promote it. These proteins are involved in cancer, infectious disease, immunity, autoimmunity, diabetes, and fibrosis, to name a few. This project will develop technologies that enable rapid discovery of CBP inhibitors, which would enable us to treat disease and to untangle the complex web of CBP functions that are currently poorly understood.